Intracellular Remodeling during Early Development

Abstract
Multicellular organisms are made of numerous types of cells. While all cells in the adult animal originate
from the fertilized egg, cellular machinery and organelles are organized uniquely in different cell
lineages. This allows different types of cells to carry out specific functions. For decades, scientists
have been focusing on how gene regulatory networks and signaling pathways control lineage
specification and differentiation. Much less attention has been given to the remodeling of the cellular
machinery and organelles during development. Whether intracellular remodeling can influence cell
fate determination and cellular differentiation represents a key knowledge gap. In an effort to
understand the mechanisms governing the oocyte-to-embryo transition (OET), which is crucial for
reproduction, we have discovered novel remodeling mechanisms that act on cellular organelles and
mRNAs in the oocyte. These include relocation of the proteasome, remodeling of the endoplasmic
reticulum (ER), regulated mRNA-ER association, and RNA phase transition during the OET. Based
on these findings, we propose to investigate the impact of ER remodeling on cell fate determination
during early embryonic development, mitochondria remodeling during oocyte maturation, and RNA
phase transition during the OET. By studying the remodeling of organelles and RNAs during early
development, the proposed studies will fill fundamentally important knowledge gaps and open a new
dimension to study post-transcriptional regulation during development.

Public health relevance
Project Narrative Since human infertility affects 10-15% of couples, a better understanding of the oocyte-to-embryo transition and early embryogenesis, which are crucial for reproduction, is highly relevant to human reproductive health. Here we propose to study the remodeling of cellular organelles and mRNAs during the oocyte-to-embryo transition and early embryonic development. Findings from our research will significantly advance our knowledge of cell, developmental, and reproductive biology.